PATHOGENESIS OF AUTOIMMUNITY IN INBRED STRAINS OF MICE

The genetic control and immunologic mechanisms of autoimmune disease is being investigated in the New Zealand strains of mice, their F1 hybrids, and recombinant-inbred lines derived from them.